Emergency General Surgery Delirium Recovery Model: A Collaborative Care Intervention

Project Summary
Delirium is a complex neuropsychiatric syndrome characterized by acute and fluctuating changes in cognition
and consciousness. Delirium survivors suffer from a cluster of cognitive, physical, and psychological
disabilities. These disabilities lead to high healthcare utilization, lower quality of life, and loss of functional
independence. Worse, a single episode of delirium increases the risk of Alzheimer disease and related
dementias. Based on work from our group and the work of others, over 25% of patients who undergo
emergency intra-abdominal surgery suffer from at least one episode of delirium during the index
hospitalization, putting them at high risk for cognitive decline. There is a fundamental gap in knowledge
regarding the best way to prevent cognitive, psychological and functional decline in patients who undergo
emergency general surgery and subsequently develop delirium. The long-term goal of this line of research is
to improve the health and quality of care for older emergency general surgery survivors. The objective of this
application is to apply the concepts of collaborative care to a high-risk patient population. Indiana University
School of Medicine and University of Wisconsin School of Medicine and Public Health researchers have over
20 years of experience developing innovative and effective collaborative care models that integrate with
primary care and specialty physicians to address the complex biopsychosocial needs of patients with chronic
disease states, such as dementia and depression. Our team has developed a specific collaborative care model
called the Emergency General Surgery Delirium Recovery Program. This proposal aims to conduct a
randomized controlled trial to evaluate the efficacy of 12-months of collaborative care in improving the
cognitive, functional and psychological recovery of emergency intra-abdominal surgery patients who suffer at
least one episode of delirium in the post-operative period and are at least 65 years old. The trial has the
following specific aims: 1) Evaluate the ability of the Emergency General Surgery Delirium Recovery Model to
improve the cognitive recovery of older Emergency General Surgery delirium survivors; and 2) Evaluate the
ability of the Emergency General Surgery Delirium Recovery Model to improve the physical recovery of older
Emergency General Surgery delirium survivors; and 3) Evaluate the ability of the Emergency General Surgery
Delirium Recovery Model to improve the psychological recovery of older Emergency General Surgery delirium
survivors. The research proposed in this application is innovative because it represents a new and substantive
departure from the status quo. Previous collaborative care models focused on chronic care management and
they lack rapid adaptability. We have also adapted the intervention to be completed solely via telehealth. This
contribution will be significant as broad application of the Emergency General Surgery Delirium Recovery
Program at hospitals across the country could result in better health and improved quality of care for a
particularly vulnerable patient population.

Public health relevance
Project Narrative The proposed research is relevant to public health because more than 1.5 million older adults undergo emergency intra-abdominal surgery and more than 25% develop delirium post-operatively. Interventions that can enhance the recovery of these patients can lead to a decrease in long-term disability and dependence of these patients. Thus, the proposed research is relevant to the NIH’s mission to develop new knowledge that will help to reduce the burdens associated with human disability.